Preeclampsia and subsequent breast cancer risk: hormonal and growth factor biomar

DESCRIPTION (provided by applicant): Layman's abstract: Women with a history of preeclampsia in pregnancy are at reduced risk of breast cancer, especially those who delivered a son, not a daughter, from the pregnancy. Why is this so? We compare hormones in the blood of a group of women who had been diagnosed with preeclampsia in pregnancy to hormones in a group who had normal pregnancies, after taking into consideration their age and other factors that influence hormone levels. We hypothesize that women with a history of preeclampsia will have lower estrogens and growth factors related to breast cancer than women who had normal pregnancies.

Public health relevance
PROJECT NARRATIVE If we discover that women with a history of preeclampsia have lower estrogens and higher androgens in their blood than women who have had normal pregnancies, then we will have an understanding why women with a history of preeclampsia are at lower risk for breast cancer than others.